Inflammatory dysregulation of vaccine responses in sickle cell disease

Abstract
Sickle cell disease (sickle cell) is the most common genetic hematologic disorder in the United States and an
increasing global health problem. Sickle cell patients have a range of acute and chronic multisystem clinical
complications and considerably shortened life expectancy. Paradoxically, despite their hyperinflammatory state,
sickle cell patients have reduced responses to vaccination, suggesting dysregulation or impairments in immune
pathways reminiscent of our studies of the chronic inflammatory milieu in aging. A broad investigation of the
systemic immune response in patients with sickle cell disease is necessary for the understanding of whether
chronic hyperinflammatory immune status may contribute to increased susceptibility to infections and reduced
responses to vaccines in this vulnerable population. We will employ recent advances in single-cell technologies
to quantify and analyze sickle cell disease patient immune status and responses to vaccinations. Our study will
provide in-depth multiparameter immune profiles and analysis to identify molecular signatures defining the
hyperinflammatory state and reduced vaccine efficacy in sickle cell disease patient populations.